Integrating Real-Time Multi-System Cytokine Signaling in Chronic Disease

Project Summary/Abstract
Over the next five years, my laboratory aims to study time-resolved systemic inflammation across multiple
chronic diseases. Though pro-inflammatory cytokine signaling is common amongst chronic diseases, it is unclear
what cytokines are active at various timepoints throughout disease initiation and progression. It is also unclear
what cytokines are functional in the inflection from acute to chronic-phase inflammatory signaling. Current
methods of research evaluation are not amenable to rapid kinetics (enzymatic immunoassays) or quantitative
multiplexing (molecular imaging techniques). We plan to use a fluorescent carbon nanosensor-based platform I
have previously developed, modified to rapidly detect pro-inflammatory cytokines in a multiplexed manner. The
multiplexed cytokine nanosensor will be encapsulated within an injectable hydrogel matrix for minimally-invasive
implantation and rapid measurement. We will use this sensor platform to create a cytokine signal detection
network for both circulating and in situ cytokine signals in rodent models of chronic diseases. The nanosensor
network will initially be validated in healthy mice using exogenous cytokine injection. We will ensure the sensor
detects multiple cytokines simultaneously, at disease-relevant concentrations, is functional for months, and
exhibits no specificity issues. The encapsulating hydrogel matrix will be designed to allow passage of proteins
but retention of the sensor based on size, and will undergo minimal biofouling. Following technology validation,
we will use the nanosensor network to measure local and circulating cytokine levels in at least eight models of
chronic disease, including: cardiovascular disease, cancer, neurodegenerative disease, and autoimmune
disease. Future work will be extended to infectious disease, chronic renal disease, musculoskeletal disease, and
others. In each disease model, we will couple traditional assessments of inflammation and immune response,
as evaluated by weekly blood draws coupled with enzymatic immunoassays. Local inflammation will also be
evaluated at the time of sacrifice via single-cell transcriptomic sequencing and immunohistochemical staining.
Kinetic cytokine measurements will be obtained via the nanosensor network, deployed in at least 7 locations in
each animal, 2 local and 2 systemic, via hydrogel injection. Each will be measured daily for kinetic cytokine
quantification prior to and immediately after disease initiation, during chronic progression, and during end-stage
disease. Sensor measurement will be performed via whole-animal imaging and simple 3-second light excitation
non-invasively from outside the animal. These sensors will provide real-time, long-term quantification of cytokine
concentrations throughout disease progression. We expect to understand kinetic cytokine changes in the
inflection from acute to chronic inflammatory responses and the pro-inflammatory contribution of multiple organs
during disease development. We will investigate pro-inflammatory cytokine signatures for each disease at
specific times in its development, providing scientists studying each field difficult-to-obtain dynamic data and
further insight into the pathogenesis of chronic disease.

Public health relevance
Project Narrative This works aims to study the role of inflammatory proteins in the development and progression of chronic disease. We will use an injectable fluorescent nanosensor network to quantify inflammatory proteins at the site of disease as well as throughout the body. We expect to understand the role of inflammation in chronic disease and to potentially discover new inflammatory signatures for different stages of each disease.